Mapping proteomic changes of tauopathy in human neurons

The accumulation and propagation of tau aggregates are key drivers of cognitive decline in Alzheimer’s disease
(AD) and frontotemporal dementia (FTD). However, our knowledge of underlying mechanisms is not yet refined
enough to meet the urgent clinical need for treatment. There is an urgent need to understand the mechanisms
underlying propagation of tau aggregates. Ratios of 3R/4R are altered by FTD mutations, suggesting differential
roles of 3R and 4R in tau pathogenesis. We recently showed that Tau-seeded 4R-P301S human neurons
develop highly robust and progressively Tau aggregation , recapitulating many aspects of Tau pathology in AD.
We also uncovered the critical roles of retromer in limiting and UFMylation cascade in promoting tau
propagation. However, the cellular mechanisms underlying Tau propagation in AD are mostly unknown though
likely affected by amyloid β (Aβ). Our overall objective is to discover AD-relevant cellular machinery
underlying the propagation of misfolded tau aggregates in human neurons using unbiased
proteogenomic approaches. To this end, we propose to combine ascorbic acid peroxidase (APEX), affinity
purification mass spectrometry (AP-MS), and transcriptomics with our newly generated knockin hiPSC lines that
express 3R/4R and 4R-P301S Tau. We propose three Specific Aims. Aim 1 will determine Tau interactomes
influenced by amyloid and Tau seeding in Tau isoforms, using advanced proteomic techniques and deep learning
analyses to prioritize genetic candidates. This will be validated in induced neurons and AD brains. Aim 2 will
focus on the role of VPS29 in tau aggregation, examining its impact on proteomic and transcriptomic profiles,
and integrate this data with human AD datasets to identify key molecular drivers. Aim 3 will explore how
UFMylation regulates tau aggregation, mapping its effects on proteomic profiles and interactions with the
retromer pathway, aiming to identify and test potential chemical interventions in AD human neuronal models.
The proposed work will be led by three teams with complementary expertise in close collaboration. Gan lab will
create proposed human iPSC neuronal and directly-programmed iN models, conduct transcriptomic profiling,
and execute various cell treatments alongside interactome purification and validation experiments. Yu lab will
perform AP-IP, APEX2-MS, and proteomics. Cheng lab will integrate genetic and proteomic data to prioritize
genetics-driven candidate genes and pathways influencing Tau pathology using network topology-based deep
learning analyses and Mendelian randomization techniques. Successful completion of the proposed study will
provide unprecedented insight into AD-related tau pathology and pave the way for novel therapeutic strategies.

Public health relevance
The accumulation and propagation of tau aggregates are key drivers of cognitive decline in Alzheimer’s disease (AD) and frontotemporal dementia (FTD). However, the cellular mechanisms underlying Tau propagation in AD are mostly unknown and likely affected by amyloid β (Aβ) through unknown mechanisms. Our overall objective is to discover how AD-relevant cellular machinery, notably the VPS29 retromer and the UFMylation pathway, underlie the propagation of misfolded tau aggregates in human neurons using unbiased proteogenomic approaches.